Mechanism and Role of Membrane Fusion by the Atlastin GTPase

Project Summary
The endoplasmic reticulum (ER) is a dynamic membrane bound organelle whose polygonal branched network
morphology is required for optimal protein targeting and secretion, lipid droplet formation and autophagy, among
others. The branched structure of the ER is sustained through recurring membrane tubule extension events
followed by homotypic tubule fusion events. The fusion events are catalyzed by the dynamin related ER
membrane anchored GTPase atlastin (ATL). Absence of ATL activity in cells causes loss of ER network
structure, while purified Drosophila ATL protein reconstituted into synthetic vesicles is sufficient to drive vesicle
fusion. Vertebrates encode three distinct ATL paralogs. ATL2/3 are expressed broadly across diverse tissues
while ATL1 is predominantly neuronal. In humans, mutations in ATL1 and ATL3 cause Hereditary Spastic
Paraplegia (HSP) and Hereditary Sensory Neuropathy (HSN), respectively. Given the vital role of the ATL
proteins in ER network homeostasis and their link to human disease, it is important to understand the respective
roles of the paralogs and their regulation. However, while the study of Drosophila ATL has enabled a detailed
understanding of the core ATL fusion mechanism, information regarding the human ATL1/2/3 paralogs, has been
scant. This has been, in large part, due to a failure to reconstitute membrane fusion by any human paralog in
vitro. In a recent breakthrough, our lab successfully reconstituted the fusion activity of all three human ATL
paralogs. In the process, we discovered extensive autoinhibitory regulation of ATL1/2 by their variable C-terminal
extensions. For ATL2, our preliminary results suggest that the inhibitory C-terminus forms a membrane inserted
amphipathic helix that holds ATL2 in an orientation incompatible with fusion. For ATL1, C-terminal autoinhibition
is less potent. However, our preliminary results also show that ATL1 both regulates, and is regulated by another
HSP protein REEP1. ATL1 promotes membrane tubulation by REEP1, while REEP1 suppresses ATL1 fusion.
In addition, a third HSP protein M1-spastin, a microtubule regulator, was reported to activate ATL1 fusion. These
findings lead to a hypothesis that the three HSP proteins regulate each other, possibly to coordinate on another's
ER structuring function. This proposal seeks to both unravel the autoinhibitory mechanisms controlling ATL1/2
fusion activity in diverse cell types (aim 1), and to test our hypothesis that ATL1, REEP1 and M1-spastin
participate in a tripartite network to maintain ER homeostasis in neurons (aim 2).

Public health relevance
Project Narrative Atlastin (ATL) GTPases are required for shaping the endoplasmic reticulum (ER), an essential subcellular organelle whose structure is important for many cellular processes. Importantly, mutations in the neuronal ATL1 paralog cause the human motor neurological disorder hereditary spastic paraplegia, but how neuronal ATL1 or the nonneuronal ATL2/3 paralogs are regulated to maintain ER structure in their respective cell types remains unknown. The proposed studies seek to uncover how this basic cell biological process is regulated as well as the basis for the human disease resulting from its dysfunction.